ADMINISTRATION AND DATABASE

The Administrative and Database Core is charged with governance of the Center, education outreach to professionals and the community, and overseeing databases for the Center's investigations. The Core will arrange external advisory visits and regular governance meetings of the investigators. The first meeting will be a special meeting of the investigators and external advisors to discuss the review of the Center and to implement any directions or changes from the review. Thereafter, it will organize an annual meeting that will bring together the investigators, the advisory board, and all trainees to fulfill the Center's special education role. Other meetings at the Society for Neuroscience and in Denver will ensure that the investigators meet at quarteriy intervals, either face to face or by teleconference. Databases to support genotypic and phenotypic analyses of human subjects and mice are maintained by the Center. The Core oversees these databases and provides for transmission of genotypic and phenotypic and clinical trials information to Core B for analyses, while maininting appropriate blind conditions for investigators Core A provides administrative, educational, and database services to all Projects and Cores.

Public health relevance
New therapeutic strategies for schizophrenia are needed to improve cognitive dysfunction and negative symptoms and to prevent the development of psychosis. The Center investigates a nicotinic acetylcholine receptor as a new therapeutic target. Investigational results are used to design a new drug treatment for schizophrenia and a preventative nutrient intervention during infant development, both of which activate this receptor.